Core A: Administrative Core

ABSTRACT: ADMINISTRATIVE CORE
The Administrative Core is the driver for the planning and coordination of all activities within the University of
North Carolina Superfund Research Program (UNC-SRP). It ensures that the research aligns with our
overarching mission - to protect vulnerable populations from arsenic-induced disease using mechanistic
and translational solution-oriented research. The role of the Administrative Core is to oversee and facilitate
the conduct of work within the UNC-SRP to ensure responsiveness to the SRP mandates. In addition to fulfilling
mandates of the SRP program, we implement research that is in line with the 2018-2023 NIEHS Strategic Plan.
This Core oversees the nine other components of the UNC-SRP.
Projects 1-2 use humanized mouse models to
characterize key developmental windows of susceptibility to iA
s-induced diabetes.
Projects 3-4 advance the
ability to predict iAs contamination in private drinking wells and develop innovative methods for enhanced
removal to reduce iAs. Four Cores include the Data Management and Analysis Core (DMAC), Community
Engagement Core (CEC), Research Experience and Training Coordination Core (RETCC), and Chemistry and
Analytical Core (CAC). The UNC-SRP Director is Dr. Rebecca Fry, a Biomedical Researcher, who is supported
in this role by Deputy Director Dr. Fernando Pardo Manuel de Villena (Biomedical Researcher) and Assistant
Directors, Dr. Mirek Styblo (Biomedical Researcher) and Dr. Orlando Coronell (Environmental Engineer). Drs.
Fry has extensive experience with administration and oversight of large research efforts, established leadership
in successful mentoring, and scientific expertise relevant to the proposal. The leadership team has
interdisciplinary expertise and experience contributes significantly to the goal of the Administrative Core is to
foster an environment that stimulates innovative science and ensures that all UNC-SRP Projects and Cores work
toward the overarching theme, “Protecting vulnerable populations from arsenic-induced metabolic
dysfunction with a vision for exposure reduction and disease prevention.” The goal of the Core is achieved
through three aims. First, we coordinate and monitor interdisciplinary research activities focused on arsenic
reduction and metabolic disease/diabetes prevention. Second, we translate the research of the UNC-SRP to
partners and end users. Third, we support community-engaged partnerships and train the next generation of
environmental scientists. Combined, these aims ensure a thriving research program bolstered by substantive
interaction with translation and community engagement partners, collectively focusing the UNC-SRP to achieve
our mission.

Public health relevance
NARRATIVE: ADMINISTRATIVE CORE The Administrative Core oversees all the Projects and Cores of the UNC-SRP toward the theme of “Protecting vulnerable populations from arsenic-induced metabolic dysfunction with a vision for exposure reduction and disease prevention.” With relevance to communities in NC and the US, the Administrative Core drives the program activities and fosters an environment that stimulates innovative science and ensures that all UNC-SRP Projects and Cores work together toward the Center’s overarching theme.